Dissemination and Outreach Core

SUMMARY/ABSTRACT – DISSEMINATION & OUTREACH CORE
Predictive and causal models – no matter the level of rigor used to produce and validate them – cannot reduce
the incidence or severity of maltreatment events unless the relevant knowledge is shared with and used by
practitioners tasked with caring for children or families at risk. The Dissemination & Outreach Core of the of the
Center on Causal Data Science for Child and Adolescent Maltreatment Prevention (CHAMP Center) will
address this crucial need by engaging the full spectrum of relevant stakeholders (domain experts, primary care
pediatricians, child welfare workers, behavioral health clinicians, agency administrators, children, and family
members) to ensure that the tools the Center develops are effective, practical, trustworthy, and safe. This core
will maximize the reach and impact of the scientific knowledge and tools produced by the CHAMP Center by
engaging these stakeholders through the processes of developing (Project 1) and testing (Project 2) decision
support tools. The Dissemination & Outreach Core will work closely with the Resources Core to create training
materials and vehicles for tools the CHAMP Center develops, including materials to communicate the largely
underappreciated potential of causal data science to prevent maltreatment and mitigate the severity of
maltreatment-related outcomes.